Thiazolino-Pyridone Compounds as Novel Antimycobacterial Drugs for Tuberculosis

Project Summary/Abstract
Tuberculosis (TB), caused by infection with the bacterium Mycobacterium tuberculosis (Mtb), is a leading
cause of global mortality, due to infection. In 2022, ~10.6 million people were newly diagnosed with TB and 1.3
million people died from the disease. As efforts to treat TB expand, the prevalence of infections caused by
drug-resistant Mtb
is increasing; in part due to the long duration (6 months) of combination therapy (4 antibiotics) for drug-
strains (DR-TB) that are resistant to one or more frontline standard of care (SoC) antibiotics,
sensitive TB (DS-TB), which leads to poor compliance. Treatment for DR-TB is even longer (typically ranging
from 6-24 months), with 3, 4, or more, antibiotics taken in combination. Despite the recent discovery and
approval of several TB drugs, including bedaquiline (BDQ), resistance is already emerging. Therefore, new
classes of drugs, with new mechanisms of action (MoAs), that can be combined with new or existing TB drugs,
are desperately needed. The success of BDQ, which disrupts energy metabolism in Mtb and is a component of
new drug regimens for DR-TB that reduce treatment times and improve outcomes, has accompanied an
explosion of drug discovery targeting respiration in Mtb. In this application, Fimbrion proposes to develop an
orally bioavailable, thiazolino-pyridone (TZP) small molecule series, with inhibitory activity against Mtb, as a
novel drug for treating TB. While the target of this compound series is currently unknown, TZPs appear to act
through disruption of Mtb respiration. Importantly, TZPs have the added property of potentiating isoniazid (INH)
activity (a key frontline TB antibiotic), against both INH-sensitive and INH-resistant Mtb in vitro; restoring
activity against the latter and reducing the emergence of INH resistance. Our project goal is to develop a first-
in-class TZP compound that could become part of a shortened, INH-containing drug regimen, that effectively
treats both DS- and DR-TB. In vitro, we have shown that exemplars of the TZP series have variable potency,
stability, solubility, and safety, with
several lead compounds have demonstrated promising pharmacokinetic (PK) profiles, with good oral
potency leads tending to have poor solubility and/or cellular toxicity. In vivo,
bioavailability (%F) and half-lives in mice, however these compounds have lacked the potency necessary for
establishing proof-of-principle (PoP) in vivo efficacy. Herein, we propose to
1) optimize and balance the
potency, safety, and drug-like properties of the TZP series, using medicinal chemistry strategies and SAR
feedback from biological assays, to identify an advanced lead series of TZPs suitable for PoP efficacy studies,
and 2) assay prioritized lead compounds: i) in vitro for activity against diverse Mtb strains and under diverse
clinically relevant conditions, and ii) in vivo for dose escalation PK and efficacy in a mouse model of acute TB.
Upon completion of this project, we expect to have identified an advanced lead series of TZPs, with good
potency, and physicochemical and PK properties capable of effectively treating TB in an animal model of Mtb
infection, which could be further developed as part of a combination therapy for TB in a Phase II SBIR.

Public health relevance
Project Narrative: Tuberculosis (TB), caused by the bacterium Mycobacterium tuberculosis (Mtb), is a leading cause of human mortality in the world for a single infectious agent and drug-resistance to standard of care frontline and even second-line antibiotics is increasing, highlighting the need for new therapies. In this application, we propose to develop a series of small molecule compounds for the treatment of TB, resulting in the selection of optimized drug candidates. The proposed studies have the potential to result in the development of a new family of anti- mycobacterials to be used to treat both drug-sensitive and drug-resistant TB.